CONFERENCE ON PROTEOLYSIS AND PROTEIN TURNOVER

The purpose of this Conference is to bring together scientists from around the world who are doing research on the forefront of the area of proteolysis and intracellular protein turnover. This conference is the Ninth of a series of International conferences that started in 1973, and have been held in Germany (East and West), Yugoslavia, Japan, and the USA. The meetings have facilitated international collaborations and the exchange of information and ideas in an important and rapidly expanding area of research. The original and continuing aim of these conferences is to bring scientists working on the biochemistry and molecular biology of proteases and inhibitors together with those working on protein turnover and processing in normal and diseased cells, tissues, and organisms. Thus scientists with very different orientations and disciplines come together to discuss the regulation and mechanisms of protein turnover at several different levels of organization. The studies and discussions will be of fundamental interest and have application to investigations of abnormal growth and Cancer, wasting diseases such as Muscular Dystrophy and Diabetes, inflammatory diseases, diseases associated with aging such as Alzheimers, and AIDS. The conference will have four major divisions: (1) Molecular Aspects of Proteolytic Enzymes and Inhibitors, (2) Cellular Aspects of Proteolytic Systems and Mechanisms of Intracellular Proteolysis, (3) Protein Turnover in T-issues and Organisms, and (4) Pathological Aspects of Protein Turnover. The conference will include 37 invited speakers, breakoff discussion sessions, and poster sessions. The conference will take place at the Hilton Hotel and National Conference Center in Williamsburg Virginia, October 18 - 23, 1992 The conference facilities are ideal for the group of 250 participants that are anticipated. The last International meeting of this series in the USA was held 8 years ago. The field has moved swiftly since then and the need for another meeting of this size and focus in the USA is acute. The conference will assemble productive and new investigators, and will help synthesize concepts, identify common mechanisms, resolve apparent conflicts, as well as stimulate new ideas, research directions, and collaborations that will lead to advances in the biomedical sciences.